Using Multivariate Mixture Models to Study Polysubstance Use with Methamphetamine in Nationally Representative and Population Samples

PROJECT SUMMARY/ABSTRACT
Methamphetamine (METH) past-year use prevalence has doubled since 2015 (from 0.51% to 1.11%), as have
METH-involved deaths. METH use represents a significant threat to public health and a challenge to treatment
efforts, as METH use is associated with substantial negative impacts on mental and physical health. There are
currently no effective pharmacological treatments for METH use disorder (MUD), and cognitive and behavioral
therapies remain difficult to access for people with MUD. Co-use of other substances (polysubstance use) and
high likelihood of developing substance use disorders are central features of METH use that increase risk for
poor treatment outcomes and contribute to METH’s disproportionate public health burden. Recent population-
level data shows that 78.2% of MUD treatment cases involve other substance use disorders. To date, studies
have focused on effects of METH use in combination with one or two other substances (e.g., opioids), but other
substances are highly prevalent among METH users and complicate the understanding of METH’s influence on
mental health, physical health and the course of METH treatment. This project aims to fill gaps in the current
literature by identifying “types” of polysubstance use with METH in the US, which may better predict outcomes
and inform the implementation and development of MUD interventions across treatment settings. This project
will be supported by an interdisciplinary mentorship team with relevant and complimentary expertise and the rich
substance use research and training environment at the University of California, San Diego (UCSD) HIV
Neurobehavioral Research Program (HNRP). The proposed R36 will utilize multivariate mixture models, large
computational structures, and two large, publicly available data sources: National Survey on Drug Use and
Health (NSDUH, 2015-2022) and Treatment Episodes Data Sets (TEDS, 2018-2021), which are published and
maintained by the Substance Abuse and Mental Health Services Administration. This proposal specifically aims
to 1) provide an updated epidemiological understanding of polysubstance use with METH in the US, 2) identify
clinically distinct subpopulations of people who use METH and examine how these differ in demography, medical
and mental health, treatment history and access, and MUD treatment outcome, and 3) identify common histories
of substance use initiation prior to METH and examine their relationship with demography, current medical and
mental health, treatment history and access, and current MUD. These aims are consistent with the National
Institute on Drug Abuse’s strategic plan to identify what substances are being used in combination, by whom,
and how these combinations may influence differential outcomes. Completion of this R36 proposal will allow me
to fulfill the doctoral dissertation requirements for a PhD in clinical psychology and expand my foundational
research skills, which I aim to leverage in building my career as an independent investigator, focused on
understanding “real world” substance use and its impact on mental and physical health.

Public health relevance
PROJECT NARRATIVE Methamphetamine (METH) use most frequently occurs in the context of other substance use (polysubstance use), but it is not currently understood how and by whom these substances are co-used, or how particular patterns of co-use shape METH’s negative impact on public health and substance use disorder treatment efficacy. The proposed research aims to improve epidemiological and clinical understanding of METH use by identifying “types” of real-world METH use in nationally representative and population-level data and examining how these are differently associated with demographic, medical and mental health, and substance use disorder treatment outcomes. Identifying sources of risk for medical and mental health comorbidities and for negative treatment outcomes will inform targeted prevention efforts and the development of more effective methamphetamine use disorder treatments.